Dietary fatty acids drive pancreatic cancer development

PROJECT SUMMARY/ABSTRACT
Despite significant advances in cancer care, pancreatic ductal adenocarcinoma (PDAC) remains the third leading
cause of cancer death in the United States with a 5-year survival rate of ~10%. Obesity and high fat diet (HFD)
consumption increase PDAC risk in human cohorts and accelerate PDAC progression in mice, but the
mechanistic basis for these relationships is not well understood. Given the rapid rise in both the worldwide
prevalence of obesity and consumption of dietary fat, deciphering mechanisms of obesity-driven PDAC could
broadly impact human health. The translational relevance of prior diet research, however, has been limited by
uncontrolled variations in fat source and intake across human populations and mouse experiments. Therefore,
whether and how specific dietary fats promote pancreatic tumorigenesis remain critical unanswered questions
of great societal importance. Leveraging a unique isocaloric panel of HFDs differing only in fat source, we
identified a correlation between consumption of diets high in oleic acid – a monounsaturated fatty acid typically
associated with good health – and enhanced tumor development in a genetic model of PDAC that faithfully
mimics the genetic and histologic progression of the human disease. We further observed that tumorigenesis
correlated with increased incorporation of oleic acid into specific phospholipids in tissues, including the pancreas.
In the parent R01 proposal, we aim to test the hypothesis that excess dietary oleic acid directly incorporates into
cellular lipids in the pancreas to drive PDAC development. Specifically, we seek to: 1) to establish whether
excess oleic acid is necessary and sufficient to promote pancreatic tumorigenesis; 2) to clarify the relationship
between dietary fatty acids and pancreatic lipid composition; and 3) to decipher the mechanisms by which dietary
oleic acid is directly taken up by the pancreas. Based on preliminary studies from the parent R01, we focus this
supplement on determining the downstream mechanisms by which dietary fatty acids alter cellular metabolism
to promote tumor formation in the pancreas. We aim: 1) to investigate how dietary modulation of pancreatic
phospholipid species perturbs lipid peroxidation and ferroptosis sensitivity in early pancreatic tumorigenesis; and
2) to determine whether excess dietary polyunsaturated fatty acids suppress pancreatic tumor progression. The
supplement will support a promising associate research scientist, enabling him to pursue these aims, acquire
additional mentorship and training in cancer biology, mouse models, lipidomics, data analysis (including
computational methods), and manuscript and grant writing. These experiences will allow him to acquire the skills
and knowledge he needs to develop an independent research career. Together, these studies will link fatty acid
consumption to specific changes in pancreatic cell metabolism as driving forces in PDAC progression. Results
from this work have transformative potential to identify novel targeted dietary and pharmacologic strategies for
the prevention of a largely incurable cancer.

Public health relevance
PROJECT NARRATIVE Obesity and excessive fat consumption increase the risk of pancreatic cancer, but how they contribute to tumor development is not completely understood. In the parent R01, we aimed to determine how dietary fatty acids directly modulate pancreatic lipid composition to drive tumorigenesis. In this supplement, we focus on the downstream effects of these dietary fatty acids on pancreatic cell metabolism, which may lead to novel targeted dietary and pharmacologic strategies for the prevention of pancreatic cancer and other obesity-driven cancers.